Integrating Multi-Scale Imaging, Reaction-Diffusion Simulation, and Markov Model Inference to Enhance Predictive Design and Interpretation of Single-Molecule Gene Regulation Experiments

Project Summary
Single-cell imaging can quantify intricate spatial and temporal dynamics of gene regulation that underly
important biomedical process ranging from bacterial infections to cancer. This gene regulation is subject to
complexities and randomness of biological processes, and its observation is further subject to measurement
artifacts due to inefficiencies in biochemical labels and distortions in microscope imaging. Yet, despite these
complications, preliminary work shows that it is possible to integrate data and computational models to predict
gene regulation in myriad environmental and genetic conditions provided that: (1) models must be constrained
by informative and reproducible data, (2) models must be rigorously verified to account for biological and
technical variations, and (3) models must be systematically explored to quantify uncertainties. The overarching
hypothesis of this project is that spatial and temporal fluctuations observed in subcellular dynamics contain
unique information that can be unlocked with improved computational methods and model-guided experiments.
To test this hypothesis, this project will create a new research platform to be known as the single-cell Graphical
Utility to Interpret and Design Experiments. scGUIDE will combine experimental analysis (e.g., image processing
and single-particle tracking to extract quantitative data from fluorescence microscopy experiments), spatial
stochastic simulation (e.g., reaction-diffusion models to generate realistic videos to mimic cellular experiments),
model abstraction and identification (e.g., parameter inference and uncertainty quantification to translate
quantitative observations into predictive insight), and experiment design (e.g., statistical methods to pinpoint
which specific experimental conditions are most likely to reveal new biological insight).
To demonstrate its broad capabilities, scGUIDE will be used to analyze and design single-cell
experiments for four different health-related processes. In yeast, the project will examine the coordination
between stress-activated MAPK dynamics and Spt-Ada-Gcn5 Acetyltransferase (SAGA) subunits that control
chromatin and RNA transcription/transport dynamics, and which have been implicated in carcinoma, skeletal
dysplasia, and retinal degeneration. In human cells, the project will examine the spatiotemporal clustering and
phosphorylation of RNAP Polymerase II as it engages in single-gene transcription under CDK-inhibitor cancer
treatments. In osteosarcoma cells, the project will explore how competition for local tRNA resources affects
translation of single-mRNA molecules in different sub-cellular regions and in human and viral contexts. Finally,
the project will explore the effects that epigenetic memory and molecular competition have on the multi-
generational activation or repression of the pap operon that allows E. coli to establish uropathogenic infections.
Each project will build mechanistic and quantitatively predictive models for how spatial and temporal interactions
of transcription or translation factors, enzymes, and complex molecular machines combine with environmental
influences to regulate expression at the single-gene, single-mRNA, single-cell, and population levels.

Public health relevance
Project Narrative This project will build novel computational tools to measure, interpret, and predict basic biological dynamics of cell signaling, transcription and translation. When integrated with single-cell experiments, these tools will support national goals to seek predictive knowledge about the nature and behavior of living systems; to enable more rapid and cost-effective health-related discoveries; and to develop the human, physical and computational resources necessary to enhance the nation's ability to prevent and treat disease.